Modeling Oral Cancer in Primary Organoid Culture

This is an application for a K08 for Dr. Salahudeen, a Hematology Oncology Fellow at Stanford University
School of Medicine. Dr. Salahudeen has commenced his postdoctoral research in cancer biology and wishes to
establish himself as a young investigator in oral cancer translational research. The K08 award for oral cancer
research will provide Dr. Salahudeen support to achieve the following goals for his career development: 1) To
demonstrate the utility of a novel 3-dimensional “organoid” in vitro oral cancer model 2) To become proficient in
the analysis of clinical, immunology, and genomics data to generate new hypotheses, and 3) to experimentally
test these hypotheses in the organoid model for further translational studies and clinical investigation. To oversee
Dr. Salahudeen’s training, he will be mentored by Dr. Calvin Kuo, an established figure in organoid culture and
cancer biology. Dr. Salahudeen will also be co-mentored by Dr. John Sunwoo, an expert in oral cancer and
immunology. In addition to his mentors, Dr. Salahudeen has assembled a group of advisors/collaborators who
will lend expertise to Dr. Salahudeen’s proposed research on oral cancer biology.
Head and neck squamous cell carcinoma (HNSCC), including oral cancer, is the sixth most common
cancer, and a leading cause of cancer-related death. However, HNSCC is a heterogeneous disease with many
clinical stratifications including Human Papilloma Virus (HPV) positive cancers, the latter of which carries a
more favorable prognosis. In contrast, HPV negative patients have a higher rate of recurrent metastatic disease.
Furthermore, HNSCC survival rates have not significantly improved in the last decade due to our limited
knowledge of disease biology as compared to other solid tumors.
To identify new driver mutations and resistance mechanisms in HNSCC, genome-scale sequencing has
identified candidate oncogenic loci but these data have not rapidly translated in preclinical studies. A major
obstacle in cancer translational research has been the substantial deficiencies of standard in vitro
preclinical models. The current art relies on cancer cell lines, patient derived xenografts grown in
immunodeficient mice, or transgenic mice bearing common oncogenes or tumor. These models are not optimal
for several reasons and there is a need for an in vitro platform that can rapidly validate candidate
oncogenic loci. To overcome these limitations, Dr. Salahudeen has developed a novel oral cancer organoid
platform to validate candidate oncogenic loci (AIM1), characterize immune evasion (AIM2), and identify synthetic
lethal therapies. In summary, the proposed training and research plan will enhance Dr. Salahudeen’s transition
to independence as a physician scientist in oral cancer translational research.

Public health relevance
Head and neck squamous cell carcinoma (HNSCC), including oral cancer, is the sixth most common cancer, and a leading cause of cancer-related death. To improve oral cancer survival, we require further knowledge of all the genes required for oral cancer growth and cancer therapy resistance. My research aims to build a 3- dimensional oral cancer model that will transcend current research methods and rapidly identify genes that may be targeted by novel therapies to improve oral cancer survival.